Optimization of Antischistosomal Chemotypes

Schistosomiasis is a tropical parasitic disease caused by infections with flukes of the genus Schistosoma,
affecting as many as 200 million individuals worldwide, with 779 million living at risk of infection. A new drug for
schistosomiasis is urgently needed as praziquantel is currently the drug of last resort and the development of
resistance cannot be ignored, particularly in view of its large-­scale use in many endemic. Our long-­term goal is
to discover a new orally active single-­dose antischistosomal drug with activities against all parasite stages and
with a novel mechanism of action. The objective of this proposal is to identify one or more antischistosomal
drug development candidates. To accomplish this objective, we will optimize four promising antischistosomal
chemotypes. We will also continue our investigation into the host-­mediated antischistosomal mode of action of
aryl hydantoin drug candidate AR102. We propose four specific aims: 1) to synthesize and characterize target
compounds; 2) to assess pharmacokinetic properties and antischistosomal activity of target compounds; 3) to
further profile selected target compounds using more rigorous assays; and 4) to investigate the mode of action
of drug candidate AR102. Compound design will be informed by existing SAR and will maximize structural
diversity guided by prospective in silico physicochemical profiling. Based on iterative feedback from
physicochemical profiling, in vitro ADME, and cytotoxicity (SA 1), ex vivo and in vivo antischistosomal activity
and in vivo ADME (SA 2 and 3), new structural hypotheses will arise, and we will synthesize additional target
compounds. Target compounds will progress through the various assays using clearly defined progression
criteria. We suggest that this proposed research is innovative for several reasons First, the aryl hydantoins and
ozonides have proven in vivo antischistosomal efficacy, but have very low ex vivo (in vitro) activity, the reverse
of the usual situation where lead compounds have in vitro but no in vivo activity. Second, the azonine keto
lactam chemotype and backup tricyclic imidazolidin-­4-­one compound series are examples of relatively rare
medium-­ring compounds (8 to 11 atoms). Third, we seek to demarcate the unique host-­mediated mode of
action of antischistosomal drug candidate AR102. The expected outcome from this work is to identify one or
more antischistosomal drug development candidates effective against all parasite stages. For antischistosomal
drug candidate AR102, we will define its host-­mediated antischistosomal mode of action. This proposed
research is significant because a new drug would be important in the chemotherapy of drug-­resistant
schistosomiasis and likely be valuable in integrated control programs to curb this parasitic disease.

Public health relevance
This proposed research is relevant to NIH’s mission because it will generate new knowledge about the structure- activity- relationship and mechanism of action of new antischistosomal chemotypes. The project is relevant to public health because the discovery of a new antischistosomal drug would be important in the chemotherapy of schistosomiasis and likely be valuable in integrated control programs to curb this parasitic disease.